Opposing Contributions of Oxytocin and Corticotropin-Release Factor to Alcohol Dependence

Project Summary
Alcohol use disorder is a global public health issue for which more effective treatments are
urgently needed. Alcohol dependence is characterized by exacerbated brain stress signaling
that drives compulsive drinking. A major component of this signaling is the pro-stress
neuropeptide corticotropin releasing factor (CRF). Oxytocin is a neuropeptide with an anti-
stress, anti-CRF profile of action, which blocks compulsive drinking in alcohol-dependent rats.
However, the neuronal circuitry through which oxytocin exerts its anti-compulsive drinking effect
is not known. Therefore, the aim of the present Pathway to Independence Award proposal is to
obtain the necessary training to identify, interrogate, and manipulate mechanisms underlying
oxytocin’s ability to block compulsive alcohol drinking. Technical training will be conducted at
the National Institute on Drug Abuse, Intramural Research Program and prepare the candidate
to use these techniques independently in the proposed and future experiments. Training will be
complimented with mentorship and career development activities tailored toward the candidate’s
goal of securing a tenure-track academic position at an extramural research institute.
Oxytocin fibers project from the hypothalamus to allow local release of oxytocin in sites
throughout the brain, including the extended amygdala, a collection of brain nuclei in which CRF
mediates dysregulated stress signaling in alcohol dependence. This proposal will first aim to
map oxytocin projections throughout the whole brain, and identify CRF cells and their co-
expression with the oxytocin receptor in terminal regions. The synaptic interaction between
oxytocin fibers and CRF cells will be determined using immuno-electron microscopy. This will
allow the identification of regions with high likelihood of oxytocin-CRF interaction. The second
aim is to use fiber photometry to monitor the activity of CRF cells in awake-behaving CRF-Cre
rats, in regions of likely oxytocin-CRF interaction. This will allow in vivo assessment of CRF cell
function in alcohol dependence, as well as in response to alcohol drinking and oxytocin
administration. The third aim is to use optogenetics to activate or inhibit the release of oxytocin
from terminal fibers in regions of likely oxytocin-CRF interaction. This will allow determination of
a causal role of local oxytocin action in alcohol drinking and other behaviors dysregulated in
alcohol dependence (anxiety and pain). Completion of these studies will provide novel insights
into the neurocircuitry and interaction of oxytocin and CRF, which have opposing roles in
alcohol dependence. The present project is of high importance for public health, given the
potentially high therapeutic value of oxytocin-based medications for alcoholism.

Public health relevance
Project Narrative Pro-stress brain signaling drives compulsive alcohol drinking in alcohol dependence, which is a common disorder and a major burden on public health. Oxytocin is an anti-stress brain peptide which blocks compulsive alcohol drinking in a rat model of alcohol dependence; however, the brain mechanism by which oxytocin exerts this effect is unknown. This project will examine the brain mechanism by which oxytocin exerts anti-stress, anti- drinking effects and may reveal new targets for the development of medications to treat alcohol dependence.